A Long Noncoding RNA SALTe Links Heart Failure to Alzheimer's Disease

Summary / Abstract
Alzheimer’s disease (AD) is the most common form of dementia in older individuals and its
incidence is increasing as the world population ages. There is no effective treatment. Epidemiological
studies have shown a strong link between AD and heart failure (HF) and the pathophysiology of AD and
HF is strikingly similar, however the biological basis for this link remains unclear. A clue may lie in the
effects of exercise, an intervention that protects against both HF and AD. We recently identified SALTe
(Senescence Associated LncRNA Transcript in exercise), a long noncoding RNA upregulated in the heart
from aged mice, HF, and downregulated by exercise. SALTe is conserved and highly expressed in
endothelial cells. In cardiac endothelial cells (ECs), SALTe overexpression induced cellular senescence
and reduced angiogenesis, while its inhibition reduced senescence and improved angiogenesis. SALTe
conferred these effects through PARP9-mediated NAD+ metabolism. Intriguingly, we found that SALTe
was elevated in brains of aged mice, whose cardiac function were impaired. Exercise reduced SALTe in
the brain and heart from aged mice. Moreover, SALTe was increased in the hippocampus from APP/PS1
transgenic AD mice. We hypothesize that SALTe works as a common mechanism contributes to the
development of HF and AD and exercise prevents or slows the development of AD by inhibiting SALTe.
To test these hypotheses, we propose to: 1. Examine the role of SALTe in AD and its prevention by
exercise, and 2. Elucidate the mechanisms by which SALTe regulates AD. We anticipate that these
studies will shed new lights into the role of SALTe in the pathophysiology of AD. Moreover, these studies
will establish clinically relevant approaches targeting SALTe to promote cognitive function in AD and
aging individuals.
1

Public health relevance
Narrative Alzheimer's disease is the most common form of dementia in older individuals and in patients with heart failure, however, the biological basis for the link of Alzheimer's disease and heart failure is unclear. Exercise promotes recovery from Alzheimer's disease and heart failure, and may serve as a platform in identifying factor linking these two diseases. The proposed research will explore the role of a novel noncoding RNA, SALTe (an inducer of heart failure), in the brain's response to exercise with the vision of establishing clinically relevant approaches targeting SALTe to promote cognitive function and cardiac health in individuals suffering from such diseases. 1